Guadecitabine-directed immune regulation in targeting prostate cancer

Project Summary
Immunotherapy has transformed the treatment landscape for many cancers, but its clinical benefit is only
marginal in prostate cancer patients. Epigenetic changes and altered immune signaling pathways can
downregulate antigen presentation, resulting in resistance to immunotherapies. There is a significant interest
in targeting cancer cells via reversing epigenetic mechanisms to modify the host intrinsic immunity. Epigenetic
therapy has the ability to activate tumor-suppressing programs and modulate the tumor microenvironment
(TME) by augmenting immune cell infiltration. In this study, we used a hypomethylating agent, guadecitabine
(gDEC), and demonstrated that gDEC leads to the upregulation of epigenetic activating enzymes contributing
to the overall prostate cancer phenotype change and anticancer effect independent of apoptosis. We also
observed that gDEC induces the level of Class I MHC molecules on the surface of prostate cancer cells,
making the cancer cells vulnerable to immune cell targets. Based on our strong preliminary data, we proposed
to test a novel hypothesis that gDEC augments the process of antigen presentation, compelling
prostate cancer cells susceptible to CD8+ T cells induced by immunotherapy. The rationale for this
hypothesis is that gDEC increases the process of antigen presentation with the potential to provoke
neoantigens, making the tumor cells immunogenic and vulnerable to immune targets. Furthermore, the
combined use of an adenovirus-based vaccine expressing prostate cancer-specific antigens (Ad-PS2 bivalent
vaccine) induces CD8+ T cell infiltration and eliminates the established tumors. Therefore, we aimed to
determine the crosstalk mechanisms between the tumor and immune cells in the prostate TME following
epigenetic remodeling and develop a novel immunotherapy regimen inducing long-lasting, antigen-specific
antitumor immunity targeting prostate cancer.

Public health relevance
Project Narrative Despite considerable progress, prostate cancer remains the second leading cause of cancer-related deaths in American men. Immunotherapy has transformed the treatment landscape for many cancers, but its clinical benefit is only marginal in prostate cancer patients. Therefore, we aimed to determine the significance of the host immunity reconstitution following combination approaches of epigenetics editing and immunotherapy targeting prostate cancer.